Optimizing Novel Immunotherapy Combinations Targeting the Tumor Microenvironment in Canine Spontaneous Osteosarcoma

Project Abstract
Spontaneous canine osteosarcoma (OS) is a well-defined large animal model of human OS, exhibiting similar
clinical presentation and molecular aberrations. Indeed, canine OS has historically been used to help develop
novel limb spare techniques, evaluate a variety of non-specific immunotherapeutics such as L-MTP-PE, and
assess the efficacy of targeted therapeutics to prevent the outgrowth of metastatic disease. Despite best efforts,
progress in the prevention and treatment of metastatic disease has essentially stalled for the past 3 decades;
30% of people and 90% of dogs still die of tumor spread, primarily to the lungs. Numerous clinical trials have
been undertaken in people with macroscopic metastases and in dogs with both microscopic and macroscopic
disease, yet all have failed to demonstrate improved outcomes. This is particularly evident with respect to
immune checkpoint inhibitors that do not induce the dramatic disease regressions typically observed in other
cancers such as melanoma and lung cancer. One particularly daunting challenge for immunotherapy-based
therapeutics in OS relates to the permissiveness of the tumor microenvironment (TME) for inducing anti-tumor
immune responses. Our data suggests that a relatively low mutational load combined with a dampened overall
immune response in OS may contribute to the observed lack of response to current treatment approaches. We
propose that targeting the immune suppressive TME in OS is essential to generating potent and durable anti-
tumor immunity. To accomplish this, it may be necessary to simultaneously modulate several elements in the
TME, including Tregs, MDSCs, M2 macrophages and overexpressed inhibitory checkpoint molecules. In support
of this, we have generated a body of data demonstrating immunological activity of multiple therapeutics, including
repurposed drugs with good safety records (losartan, oclacitinib), small molecule inhibitors with established
PK/PD in dogs (toceranib, RV1001, reparixin, JHU-292) and antibodies specific for checkpoint molecules (anti-
PD1). However, the exact combinations that are most effective against metastatic OS have not yet been
identified, and this is a major goal of this proposal. As such, we hypothesize that an adaptive pilot trial design
can be used to rapidly screen TME-targeting immunotherapy drug combinations in dogs with
macroscopic chemotherapy-resistant metastatic OS and that this information can be refined to assess
activity of the most active approach against microscopic metastases in a subsequent adjuvant trial. This
will be accomplished by testing four TME modifying immunotherapy combinations for anti-tumor and immune
modulatory activity in dogs with macroscopic OS metastases, interrogating relevant biomarkers associated with
responses to therapy, then using this information to conduct an adjuvant immunotherapy trial with the most active
combination in dogs with microscopic metastatic OS. The data generated from this proposal will create a
blueprint for future immunotherapy studies in people with OS by eliminating approaches deemed inactive
and generating a set of clinical biomarkers to guide treatment.

Public health relevance
Project Narrative Despite a multitude of clinical trials geared to eliminating tumor spread, approximately 30% of people with osteosarcoma (OS) still die of disease. We will use dogs with spontaneous OS to test a series of promising novel immune therapies and leverage this data to create a blueprint for future human trials.